Administrative Core

Abstract
The Administrative Core (Core A) of the Center for Cancer Biology Research (CCBR) at Sanford Research is
not only essential for all research activities occurring within the CCBR but also for that within Sanford Research
as a whole. The funds requested in Phase III will provide continued support for the Principal Investigator,
Program Coordinator and Project Manager. These key individuals are responsible for the overall administration
of the CCBR. We also propose to fully support the Lead Research Technician and Senior Research Specialist
of the Histology & Imaging Core (Core B) as well as a Manager and Technician in the Flow Cytometry Core
(Core C). We will additionally support a Pilot Grant program to ensure continued funding of innovative research
in the region and use of the CCBR's Scientific Cores. A Steering Committee composed of previous CoBRE
Project Leaders as well as Sanford Research leaders will ensure successful functioning of the Scientific Cores.
An External Advisory Committee, composed of leaders in the Cancer Biology field, will work with external
reviewers from North Dakota State University, the Administrative Core and the Steering Committee to select
Pilot Grant awardees and resolve any issues that may arise within the CCBR or its Scientific Cores. The
Administrative Core will accomplish the following Specific Aims: 1) To support the existing Scientific Cores,
enabling self-sufficiency and 2) To continue a program of Pilot Grants. In order to achieve these goals, the
Administrative Core will meet twice a year (Fall and Spring) with the Steering and External Advisory Committees.
The Spring meeting will serve as a review of the program and evaluation of the Scientific Cores as they work
towards self-sustainability. Importantly, the Administrative Core will prioritize and oversee the allocation of funds
such that they meet institutional strategic needs and are in line with the NIH mission. Moreover, the
Administrative Core will continue to focus on the CCBR's existing areas of cancer research while expanding to
include additional innovative and impactful areas. The CCBR will have the following focus areas: 1) tumor
innervation, 2) tumor immune response, 3) tumor microenvironment and 4) tumor development. The ultimate
goals of the Administrative Core are to continue funding cancer research in the region and to bring the CCBR's
Scientific Cores to self-sufficiency. The plan laid out in this section will ensure success of the CCBR.